MOLECULAR DYNAMICS OF PHOTODAMAGED DNA DECAMER

Our work involves particle mesh Ewald studies on a DNA decamer and its photodamaged analogs. Specifically, we have model built the non-damaged decamer and the resulting thymine dimer and the 6-4 adduct in water. We minimized and equilibrated these systems using the Sander module of Amber 4.1 and are presently subjecting the equilibrated structures to unrestrained 1fs molecular dynamics simulations. For this project we have used the computer graphics facilities to visualize the DNA decamers. In addition, we have used the Computer Graphics Lab to examine a variety of enzymes implicated in the repair of photodamaged DNA available through the PDB. For example, we have visualized T4 endonuclease V, whose crystal structure was recently reported by K. Morikawa. Upon completion of our molecular dynamics study of the decamers we will undertake a computational study of the enzymatic repair process.